Development of Light Triggered Molecular Tools Critical for Understanding the Brain's Network

Development of Light Triggered Molecular Tools
Critical for Understanding the Brain’s Network
PI: Nasri Nesnas, PhD
PROJECT SUMMARY
Brain disorders, such as dementia, epilepsy, and depression, continue to be a major challenge in
medicine. This is not surprising considering the enormous complexity of the brain’s network of
neurons. An average human brain incorporates nearly 86 billion neurons intertwined with as many as
10,000 synaptic connections. Such complexity is far more colossal than any computer processor or
even the entire worlds’ road maps. Therefore, brain-mapping efforts have become of apparent
urgency to enable a better understanding of this complex maze.
Making substantial advances in this area certainly requires collaboration of multiple disciplines. Light
responsive molecular tools have become indispensible to neuroscientists as they provide means to
manipulate specific neuronal connections with precise timing. We established collaborations with
several neuroscientists, including Attila Losonczy of Columbia University to design and use these
critical tools. They are investigating the role of calcium ions in learning and memory. We propose to
develop molecular tools that can precisely modulate the concentration of calcium ions using photo
switchable chelating systems.
Photocleavable protecting groups, also known as cages, enable the release of active agonists with
light. The principal advantage of this technique is the unparalleled precision of activation in location
as well as timing, otherwise referred to as spatio-temporal control. We have prepared several of
these cages, and we aim to design more efficient ones that can also respond in visible and near IR
wavelengths to avoid photo toxicities associated with UV light traditionally used. Tamoxifen has been
used as a ligand for inducing gene expression in Cre-ER Lox systems. We propose to prepare caged
tamoxifen to enable our collaborator to use precise temporal control of gene expression in
hippocampal cells. Preparation of effective photoactive molecular tools will directly benefit the larger
neuroscience community in studying the brain with the level of detail essential to treating elusive brain
disorders.
I will continue to actively engage undergraduate students in these endeavors, and particularly
emphasize the diversity of educational and cultural backgrounds of the members in my research lab.
I have been successful at maintaining a larger percentage of female students than our university’s
average and I will continue to do so as well as encouraging minority students to engage in research.

Public health relevance
Project Narrative (Relevance) Brain disorders like Autism, Alzheimer’s, epilepsy, Huntington’s, Lou Gehrig’s, depression, and others remain elusive to comprehend and treat. The unparalleled complexity of the human brain, with its 86 billion neurons intricately linked by thousands of connections, presents a formidable challenge. This proposal endeavors to develop light-controlled molecular tools, acting as neuron switches, to revolutionize our understanding of brain connectivity and function thus potentially unlocking groundbreaking treatments.